Regulation of 22q11 Genes in Embryonic and Adult Forebrain

ABSTRACT
Layer 2/3 projection neurons (PNs) are critical nodes in association cortico-cortical (Ac-c) circuits, and likely
targets of neurodevelopmental disorder (NDD) pathology. In mouse models of 22q11.2 Deletion Syndrome
(22q11DS), which in humans confers risk for multiple clinically defined NDDs, Ac-c circuits are under-
connected, in part due to diminished layer 2/3 PN growth accompanied by mitochondrial oxidative stress. We
will use mouse 22q11DS genetic models to test the hypothesis that Ac-c circuit pathology in NDD reflects
selective, mitochondria-dependent developmental dysregulation of layer 2/3 PN long-range
connections, leading to disordered synaptic organization, disconnection, and dysfunction. We combine
genetic, physiological, transcriptomic, proteomic, and behavioral approaches to assess how 22q11 deletion
alters identity and function of layer 2/3 PNs to result in individually variable behavior and circuit pathology. In
Specific Aim 1 we determine whether excitatory (E) vs. inhibitory (I) synaptic sites on layer 2/3 PNs that make
long-range connections are altered by NDD pathogenesis, including that due to 22q11 deletion, leading to Ac-c
circuit disconnection and dysfunction. Our data will provide foundational insight into cellular, physiological and
transcriptional identities of typical layer 2/3 Ac-c vs. 5/6 PNs, as well as consequences of NDD pathology for
E/I balance in circuits defined by long-range Ac-c connections. In Specific Aim 2, we assess mitochondrial
function in developing layer 2/3 PNs as they generate pre- and post-synaptic domains to define mature
microcircuits. We analyze how NDD pathogenesis due to 22q11 deletion disrupts developing and mature
mitochondrial regulation of Ac-c connectivity. Our data will provide fundamental characterization of
mitochondria deployment, bioenergetics, and proteomic identities in typical developing and mature layer 2/3 vs.
5/6 PNs, including mitochondria at layer 2/3 PN synapses. In parallel, we will define how mitochondrial identity
and function is compromised by 22q11 deletion. In Specific Aim 3, we analyze how mitochondrial antioxidant
defense influences behaviors that rely upon long range Ac-c connections made by layer 2/3 PNs. We assess
individual variability in cognitive, mnemonic, sensory gating and social behaviors. Our data will resolve whether
a specific dimension of mitochondrial function—clearance of reactive oxygen species generated by oxidative
phosphorylation—varies individually to disrupt Ac-c circuit dependent behaviors and circuits. Data collected
from these Specific Aims will provide a framework for understanding optimal mitochondrial regulation of Ac-c
circuit development and function and its disruption in NDDs. We will resolve contributions of mitochondrial
function and antioxidant defense to 22q11 deletion-mediated Ac-c disconnection and related behavioral
deficits. Our work will define whether emerging therapies, including antioxidants and other metabolic
interventions can restore or preserve essential connections and function in NDD.

Public health relevance
NARRATIVE Disconnection and physiological dysfunction of interconnected association regions of the cerebral cortex that regulate cognitive functions is thought to be a primary pathology in multiple neurodevelopmental disorders, including schizophrenia and autistic spectrum disorder. This project will determine whether the neurons that interconnect association cortices—layer 2/3 projection neurons—are the target of NDD pathology due to oxidative stress caused by dysfunctional mitochondria. The data will define potential targets for novel therapies to ameliorate mitochondria-related circuit dysfunction and behavioral deficits in a broad range of NDDs.